STING inhibition as a therapeutic target for endometriosis

Project Summary/Abstract
Endometriosis affects about 10% of all reproductive-age women and it is one of the main causes of pelvic pain
and infertility. Current FDA-approved hormonal therapies are often limited in efficacy, counterproductive to
fertility and with side effects affecting endogenous hormone steroid levels, resulting in cessation of the
reproductive cycle, hirsutism, postmenopausal symptoms, and osteoporosis. Alternative therapeutic strategies
are geared towards drugs without hormonal side effects but with limited therapeutic efficacy, including NSAID
treatment for pain. To date, no effective therapies without hormonal side effects exist. Thus, studies aimed at
identifying novel therapeutic targets against endometrial inflammation and fibrosis devoid of unwanted side
effects stemming from estrogen deficiency, is a major clinical need. Recent evidence indicates that stimulator
of interferon genes (STING) is upregulated in endometriosis lesions and recent data from our team and others
show that type I and II (IFN) are associated with more advanced stages of endometriosis, independently of the
menstrual cycle and hormonal status, with STING-dependent IFN related genes emerging as novel stromal
markers of endometriosis. Nitro-fatty acids (NO2-FAs) have emerged as potent anti-inflammatory and anti-
fibrotic agents in numerous experimental models of inflammation, metabolism and fibrosis, and successfully
completed phase I and II clinical trials. Our collaborators identified residues Cys88 and Cys91 of STING as
NO2-FA targets. In addition to the first generation NO2-FAs, we identified NO2-FA-derived New Chemical
Entities (NCEs), compatible with oral delivery and showing high efficacy on STING inhibition and negligible
toxicity in vivo. Considering the unique pathogenesis of endometriosis, involving endometrial inflammation and
fibrosis along with the well-established anti-inflammatory and anti-fibrotic properties of NO2-FA, we show that:
1) oral delivery of a first generation NO2-FA, NO2-conjugated linoleic acid, protects against endometriosis in a
syngeneic model in vivo; 2) Loss-of-STING function protects against experimental endometriosis; 3) A novel
NCE, CP-36, with improved STING affinity (IC50) and low toxicity in vivo is readily bioavailable as an oral
therapy against endometriosis. Based on these premises, the project will test the central hypothesis that
novel orally bioavailable STING inhibitors protect against endometriosis and associated pain by inhibiting
inflammation and fibrosis. Using our unique mouse model, STING C88A/C91A knock-in, click chemistry, and
well-established models of peritoneal endometriosis, including a regression study, we will define the
therapeutic specificity of CP-36 as bona fide STING inhibitor in endometriosis (aim 1) and establish that STING
inhibition by oral delivery of CP-36 reduces endometriosis (aim 2). This study will provide functional and
mechanistic evidence for novel NO2-FA-based STING inhibitors as potential non-hormonal therapeutic drugs
for endometriosis, thus paving the way for the accelerated development of novel therapeutic strategies and a
paradigm change in clinical treatment and management of this disease.

Public health relevance
Project Narrative: Endometriosis affects about 10% of reproductive-age women and is one of the main causes of pelvic pain and infertility. The proposed project is relevant for the public health because it will provide functional evidence towards the assessment of STING inhibitors effects in endometriosis and associated pain, paving the way for the development of novel non-hormonal therapeutic strategies, based on nitro-fatty acids.